Smart Self-Sterilizing Dental Composites for Class V Restorations

Summary Dental caries continues to be a public health issue, especially more evident in underserved populations throughout the U.S. Unfortunately, especially with an ageing population, hundreds of thousands of resin composite restorations are replaced each year due to recurring decay and fracture. According to a number of cohort studies, the average life-span of this type of restoration is 7 years or less, depending on the caries risk level of the patient and on the complexity of the restorative procedure. Class V lesions, carious or non-carious in nature, are particularly challenging to restore due to the location of the margins (often in dentin/cementum), the complexity of load distribution in this area of the tooth and the tendency for greater biofilm accumulation near cervical areas. This proposal represents an effort to develop novel pH- responsive, self-sterilizing methacrylamide composites capable of overcoming the aforementioned difficulties and increasing service life of class V restorations, thus saving millions of dollars annually and the unnecessary loss of additional tooth structure. The proposed approach will improve the longevity of class V restorations by: 1. Designing monomers, based on biocompatible carboxybetaine (CB) chemistry, that are capable of responding to acidic challenges in the oral environment and performing the dual function of antifouling surfaces (at neutral pH) and bactericidal surfaces (at low pH). 2.Utilizing polymerizable functionalities that depart from the water/esterase-labile methacrylates. Methacrylamides are well known for their resistance to degradation by hydrolysis, and the systems proposed here will also be stable to enzymatic attack (through the use of tertiary methacrylamides). 3. Incorporating toughening additives, based on pre-polymerized thiourethanes, which not only reduce the concentration of polymerizable functionalities (thus reducing shrinkage), but can also delay polymer gelation (thus reducing stress). In addition, the oligomer will be functionalized to work as a carrier of the CB moiety. 4. Promoting self-adhesive, ionic/covalent interaction between the substrate and the adhesive layer, in addition to the already existing micro-mechanical interlocking. This will allow for the use of less aggressive (if any) acid etching of the substrate, decreasing activation of deleterious MMPs.

Public health relevance
Narrative With an aging population in the US, root caries have become more prevalent. This site in the oral cavity poses unique challenges to the restorative procedure, such as margins predominantly in dentin and cementum, a greater risk for plaque accumulation and complex distribution of mechanical forces. Further, many of the people affected by such lesions suffer from physical issues that hamper their ability to clean these difficult areas, and from xerostomia associated with medications. Enhancements in the restorative materials’ reliability and clinical longevity would offer significant health care benefits to the general public, and specifically to this most susceptible population. The new polymer system we are developing will produce a restorative with the capacity to repel and kill oral bacteria, thus minimizing biofilm formation and reducing caries formation, as well as presenting significantly reduced degradation in the oral environment to enhance restoration longevity. The new materials will also be self-adhesive, producing more durable bonding between the restoration and tooth structure, which should minimize recurrent decay and delay or eliminate restoration replacement. The incorporation of additives to the new, novel polymers provides a simple, relatively low cost means to achieve this goal, without requiring modifications to the current operatory techniques, thus facilitating their prompt practical application.